Malaria Transmission and the Impact of Control Efforts in Southern and Central Africa

Abstract
The Southern Africa International Centers of Excellence for Malaria Research (ICEMR) has been highly
successful, with 19 peer-reviewed publications of primary research findings at the time of this application, co-
authorship on seven additional ICEMR-related reviews, and research findings that have been translated into
policies. Through integrated studies of malaria epidemiology and vector bionomics in three different
transmission settings in Zambia and Zimbabwe, we developed detailed understanding of the drivers of malaria
transmission at each site, identified key barriers to control and elimination, and informed policy decisions to
improve control strategies. In this renewal application, we will build upon the infrastructure, expertise and
relationships developed by the Southern Africa ICEMR over the past six years to further advance malaria
control and elimination in a critical geographic expanse, extending from a setting of highly seasonal malaria
transmission in eastern Zimbabwe on the border with Mozambique, through the pre-elimination setting in
southern Zambia, to the high transmission settings in northern Zambia and southeastern Democratic Republic
of Congo (DRC). This region is the focus of intense malaria control and elimination efforts, including those of
the President's Malaria Initiative, United States Agency for International Development, Bill & Melinda Gates
Foundation and the Global Fund to Fight AIDS, Tuberculosis and Malaria as well as numerous smaller regional
initiatives such as Elimination 8. No other research group in southern Africa has studied the barriers to control
and elimination in such depth, duration and across such a range of transmission settings. Continuing and
building upon the research activities of the Southern Africa ICEMR will be critical to the success of these
investments and the control and elimination of malaria in southern Africa. Our theme is to address critical
research questions on barriers to malaria control and elimination in Southern and Central Africa, specifically
explanations for continued malaria in high, moderate and low transmission settings despite current public
health interventions.

Public health relevance
Narrative The Southern Africa International Centers of Excellence for Malaria Research (ICEMR) has been highly successful. Through integrated studies of malaria epidemiology and vector bionomics in three different transmission settings in Zambia and Zimbabwe, we developed detailed understanding of the drivers of malaria transmission at each site, identified key barriers to control and elimination, and informed policy decisions to improve control strategies. We will build upon the infrastructure, expertise and relationships developed by the Southern Africa ICEMR over the past six years to further advance malaria control and elimination in a critical geographic expanse extending from Zimbabwe to the Democratic Republic of Congo.